Production of 3D Bioprinted Autologous Vaginal Tissue Constructs for Reconstructive Applications

PROJECT SUMMARY
Many congenital and acquired conditions resulting in the abnormality of the vagina often require reconstructive
surgery to achieve anatomical and physiological function. Unfortunately, reparative procedures are challenged
by the availability of vaginal tissues. Unfortunately, the use of non-native vaginal tissues and biomaterial
substitutes has contributed to various complications, including mechanical, structural, functional, or
biocompatibility problems. It is evident that native vaginal tissue, with its inherent functional properties, is most
suitable for surgical reconstruction. Recent advances in tissue engineering and regenerative medicine have
provided a solution to create autologous tissues for various clinical applications, including skin, bone, cartilage,
urethra, and bladder. Applying the principles of tissue engineering, we have previously applied bioengineered
autologous neovaginal tissues to create a functionally normal vaginal vault in pediatric patients born with vaginal
aplasia. Due to the varying levels of pathologic conditions in each patient, manufacturing the target
bioengineered vaginal tissue construct for reconstruction is challenging, requiring a better solution to
meet the clinical needs. 3D bioprinting technology has emerged as a solution to develop patient-specific
personalized tissue constructs with precision and reproducibility, addressing the current translational limitation
of biomanufacturing for wide reconstructive applications. To address this unmet clinical need, our central
hypothesis is that developing a bioprinting workflow will permit the fabrication of personalized autologous vaginal
tissue constructs for clinical use. Thus, the objective of this study is to establish a clinically applicable 3D
bioprinting workflow to manufacture personalized autologous vaginal tissue constructs that consist of
patient-derived vaginal epithelial cells (EPCs) and smooth muscle cells (SMCs) for vaginal tissue
reconstruction. The central hypothesis will be tested by pursuing three Specific Aims: 1) Develop and optimize
a bioprinting workflow to bioengineer a readily implantable vaginal tissue construct; 2) Validate the individualized
bioprinted vaginal tissue constructs using a preclinical animal model; 3) Establish a process development and
batch record for regulatory approval. Successful completion of the proposed work will provide a standardized 3D
bioprinting workflow that generates personalized vaginal tissue constructs with the required precision for vaginal
tissue reconstruction. Using personalized autologous bioengineered tissue constructs will significantly impact
patient care and change how we approach vaginal reconstruction in growing children and adults.

Public health relevance
PROJECT NARRATIVE We propose to develop 3D bioprinted personalized autologous vaginal tissue constructs consisting of patient- derived vaginal epithelial and smooth muscle cells for surgical reconstruction. We will utilize clinically applicable 3D bioprinting workflow to manufacture patient-specific vaginal tissue constructs for long-term use, adapting to the needs of growing children and adults. This study will explore the potential of utilizing a 3D bioprinting strategy in a clinically relevant surgical animal model and establish a process development and batch record for regulatory approval.